A Translational Bioinformatics Approach to Rescuing Synaptic and Neurophysiologic Dysfunction in Alzheimer's Disease

Program Director/Principal Investigator (Last, First, Middle): Teich, Andrew, Franklin
Project Summary
The goal of this proposal is to identify FDA approved compounds that will rescue synaptic dysfunction in
Alzheimer’s Disease (AD). This goal is motivated by the observation that one of the earliest events in AD is
synaptic dysfunction. In microscopic post-mortem studies, synaptic loss correlates strongly with pre-mortem
cognitive status, and serves as a better predictor of pre-mortem cognitive status than either plaque or tangle
pathology. Faced with this evidence, multiple groups have proposed that synaptic dysfunction is central to the
pathophysiology of AD. Our laboratory has previously utilized novel datamining techniques on RNA expression
data to identify master regulators of synaptic and neurophysiologic dysfunction in AD. This computational effort
has identified transcriptional regulators whose dysfunction in AD is predicted to cause impairment in
expression of synaptic genes (we refer to these transcriptional regulators as “synaptic master regulators,” or
synaptic MRs). Using similar techniques, we propose to screen a library of FDA-approved compounds for their
ability to support synaptic function in AD by appropriately modifying disease-relevant synaptic MRs. At the end
of this project, we will have a list of FDA-approved compounds that rescue synaptic MR dysfunction. Although
this is the primary endpoint of this project, we will also generate the following secondary deliverables; 1) A rat
neuronal interactome, which predicts a regulon for every transcriptional regulator in rat neurons, 2) A human
iPSC neuronal interactome, which predicts a regulon for every transcriptional regulator in human iPSC
neurons, and 3) A list of all transcriptional regulators affected by a library of FDA-approved compounds. These
additional deliverables will be usable for drug discovery of other neurologic diseases.
OMB No. 0925-0001/0002 (Rev. 03/16 Approved Through 10/31/2018) Page Continuation Format Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Teich, Andrew, Franklin Project Narrative Alzheimer’s disease (AD) is the number one cause of dementia in the western world, and is a major cause of mortality and morbidity. One of the most important causes of dementia in AD patients is loss of function at synapses; synapses are the connection points between neurons, and these connections become dysfunctional in AD. In this proposal, we are screening for drugs that will support the function of these connections, which we hypothesize will directly benefit people with AD dementia. OMB No. 0925-0001/0002 (Rev. 03/16 Approved Through 10/31/2018) Page Continuation Format Page